Adaptation and optimization of the Friendship Bench mental health intervention for adolescent girls and young women in South African PrEP delivery settings

ABSTRACT
The goal of the proposed K99/R00 award is to support Dr. Jennifer Velloza’s development into an independent
HIV and mental health researcher, with a focus on improving delivery of mental health interventions integrated
with HIV prevention services for young women. Dr. Velloza is an epidemiologist and postdoctoral fellow at the
University of Washington. This proposal outlines a 5-year training and research plan to build her capacity with
formal training in human-centered design and implementation science. Training Plan: To ensure transition to
independence, Dr. Velloza has assembled a multidisciplinary team of mentors and advisors with expertise in
human-centered design, implementation science, and PrEP and mental health service delivery for South African
adolescent girls and young women (AGYW). They have crafted a robust training plan with meetings and relevant
coursework. The training goals for the K99 are to: 1) Gain proficiency in human-centered design for intervention
adaptation; 2) Apply implementation science tools to identify implementation strategies for integrating a mental
health intervention in PrEP delivery; and 3) Transition to independence by leading a trial to test and optimize a
mental health intervention for South African AGYW in PrEP settings. These goals build on her prior experience
and training and support her long-term career goals. Research Plan: African AGYW face high rates of HIV and
common mental disorders. PrEP is a highly effective HIV prevention approach which is being scaled up in South
Africa. However, symptoms of common mental disorders are significant barriers to PrEP use and the South
African Department of Health is placing increasing emphasis on layered approaches to PrEP delivery for AGYW.
Effective mental health treatment, such as problem-solving therapy (PST), has the potential to be integrated with
PrEP delivery to address mental health challenges and modifiable barriers to PrEP use and improve PrEP
adherence for AGYW. The Friendship Bench is a promising evidence-based PST intervention option for AGYW
in PrEP settings given that it was developed for delivery in busy HIV clinics, is currently being scaled-up in South
Africa, and preliminary data suggests it can be adapted to improve HIV treatment adherence among African
women. Research is needed to adapt intervention content, evaluate effectiveness on mental health and PrEP
adherence outcomes, and identify implementation strategies for AGYW in PrEP delivery settings. The overall
goal of this proposal is to adapt, test, and optimize the Friendship Bench for African AGYW in PrEP delivery.
The Specific Aims are to: 1) Identify content for a mental health intervention and barriers to implementation in
PrEP clinics; 2) Design and pilot Youth Friendship Bench SA content and implementation strategies; 3) Conduct
a hybrid Type II trial to assess preliminary effectiveness of Youth Friendship Bench SA on PrEP adherence while
optimizing implementation for cost constraints in PrEP delivery; and 4) Identify themes around intervention
experiences. These aims correspond with Dr. Velloza’s training goals and she will emerge as an independent
scientist contributing to high priority issues around mental health and HIV prevention service delivery.

Public health relevance
PROJECT NARRATIVE In previous studies with adolescent girls and young women (AGYW) at risk of HIV in sub-Saharan Africa, 20- 50% have symptoms of common mental disorders (e.g., depression, anxiety, stress) which are associated with suboptimal adherence to HIV pre-exposure prophylaxis (PrEP), a highly effective HIV prevention approach. In this K99/R00 project, the candidate, an epidemiologist and behavioral scientist committed to HIV and global mental health research, seeks to address poor PrEP adherence and mental health among AGYW at risk of HIV by adapting, testing, and optimizing an evidence-based mental health intervention for the context of PrEP delivery. This study will provide important insights on approaches for integrating mental health interventions in PrEP delivery and the optimized intervention has the potential to improve both PrEP adherence and mental health outcomes for AGYW in South Africa and other high burden settings.